Hydrogels for delivery of muscle stem cells to diaphragm

PROJECT ABSTRACT Duchenne muscular dystrophy (DMD) is an X-linked genetic disease that affects ~1 in 3,500 newborn males and is characterized by progressive muscle wasting and weakness. As a result, patients suffer from ambulatory disability, cardiac failure, and respiratory failure, the latter of which is a major contributor to premature death. Current treatments for respiratory care remain palliative, as there is no cure for DMD. The primary cause for DMD is the absence of functional dystrophin, a protein that provides structural support between the sarcolemma and extracellular matrix. A strategy for restoring dystrophin is to transplant satellite cells to a target muscle. Although this strategy would not be an efficient method to treat DMD throughout the body, the diaphragm muscle presents a viable and important target for the delivery of satellite cells due to its vital role in respiratory function. Upon successful engraftment of satellite cells to the diaphragm muscle, dystrophin, muscle excitability, and respiratory function can be restored, extending a DMD patient’s life expectancy, and improving the quality of life by potentially bypassing the need for mechanical ventilation. Delivery of satellite cells to the diaphragm muscle poses a challenge due to sub-optimal engraftment, survival, and function of transplanted cells, as well as the diaphragm’s thin dimensions and deep-seated location. This project seeks to overcome these hurdles by engineering a synthetic hydrogel-based bioactive cell injectable vehicle to deliver satellite cells to the dystrophic diaphragm and promote survival, expansion, differentiation, and engraftment of transplanted cells to improve diaphragm function. The goals of this proposal will be accomplished in a stepwise fashion. First, we will engineer synthetic hydrogels functionalized with adhesive peptides to maintain and direct muscle satellite cell function in 3D, including adhesion, survival, expansion, and differentiation. Second, we will evaluate the extent to which engineered hydrogels allow for delivery and engraftment of GFP+ muscle satellite cells in the diaphragm of mdx/mTR mice and the extent to which the diaphragm’s function improves. Successful outcomes in this work will have broad significance and impact by demonstrating the potential of this strategy as a treatment for respiratory failure in DMD patients. Rather than relying on mechanically assisted ventilation, a patient receiving this treatment can benefit from an extended and improved quality of life. Additionally, this work will build on a broader goal to demonstrate that designing biomaterials for stem cell delivery and engraftment to musculoskeletal tissue is a feasible strategy for encouraging regeneration of the targeted tissue.

Public health relevance
PROJECT NARRATIVE Duchenne Muscular Dystrophy (DMD) is a genetic disorder in which a patient lacks a functional dystrophin protein. As a result, patients suffer from respiratory failure and premature death. We will engineer bioactive synthetic hydrogels to deliver satellite cells to the dystrophic diaphragms in order to restore dystrophin. This can lead to improved diaphragm functionality, thus demonstrating the potential for this strategy to enhance respiratory function in DMD patients.